Disentangling the Epidermal Immune Crosstalk in Inflammatory Skin Disease

Project Summary/ Abstract
Inflammatory skin diseases are often multifactorial, with influences from genetics and environmental factors that
cause immune dysregulation and impair skin barrier integrity. The epidermis is the outermost layer of the skin
and is fundamental to maintaining skin barrier integrity. Also, epidermal skin cells play a primary role in the
recruitment and regulation of immune cells upon disruption of homeostasis. The mechanisms that govern the
crosstalk between the epidermis and the immune system have yet to be fully elucidated. Current strategies in
treating inflammatory skin disease include the administration of corticosteroids and retinoids, which may have
unwanted side effects with prolonged use. Therefore, there is a need for a better mechanistic understanding of
the crosstalk between the epidermis and the immune system to develop more targeted approaches to treat
inflammatory skin disease. Recent reports have implicated SNPs in genes that may play a role in inflammatory
skin diseases. One such gene is Ovol1. Ovol1 is a transcriptional repressor of immune cell recruitment and is
necessary for maintaining skin homeostasis and regulating proper embryonic epidermis development. Ablation
of Ovol1 in psoriasis-like and atopic dermatitis animal models exacerbates disease with an increase of infiltrating
neutrophils. Ablation of neutrophils improves disease outcomes.
Neutrophils are the principal innate immune responders forming the first line of defense against pathogenic
invaders or sterile damages. Neutrophils have an arsenal of effector functions, including the engulfment of
pathogens, release of proteases, extracellular trap formation, and release of reactive oxygen species.
Appropriately, neutrophils have a destructive potential that requires stringent regulation of recruitment to avoid
excess collateral damage to the host. Our preliminary data show that in the absence of epidermal Ovol1, the
recruitment of neutrophils to the injured skin increases in minutes. This observation suggests that Ovol1 has a
gatekeeping function and prevents the excessive production of neutrophil chemoattractants after skin injury. My
central hypothesis is that Ovol1 regulates the production of leukotrienes as well as the expression of
chemokines before or minutes after wounding. The absence of epidermal Ovol1 primes the skin for neutrophil
infiltration, in turn exacerbating inflammatory skin disease. In this proposal, I will address two aims to support my
hypothesis: 1) Evaluate the role of leukotrienes in the excessive recruitment of neutrophils in the absence of
epidermal Ovol1, 2) Identify and block chemokines expressed early after skin injury when Ovol1 is absent. The
proposed research will untangle the early crosstalk between the epidermis and the innate immune system,
potentially revealing better pharmacological targets to alleviate inflammatory skin disease.

Public health relevance
Project Narrative: Inflammatory skin diseases are often multifactorial with influences from genetics, such as SNPs in Ovol1, and environmental factors, like irritants in the air, that cause immune dysregulation and impair skin barrier integrity. Neutrophils are the principal innate immune responders forming the first line of defense against pathogenic invader or sterile damages; however, their recruitment requires tight regulation to avoid damage to the host. The proposed research will untangle the early crosstalk between the epidermis and innate immune system, potentially revealing better pharmacological targets to alleviate inflammatory skin disease.